Optimizing in vivo dLight recordings for investigating the influence of disease on dopamine signaling.

Project Summary
This proposed research aims to provide a roadmap for studying dopamine dynamics using a novel optical tool,
dLight, deepening our understanding of dopamine biology. Altered dopamine signaling is central to many
neurological and neuropsychiatric disorders, yet we lack effective treatments for these disorders. Many existing
treatments act on dopaminergic systems, but they act on slow time scales and do not work for all patients.
Deepening our fundamental understanding of dopamine biology can lead to the discovery of improved
treatments. The Tian lab developed dLight, which is an optical biosensor that can directly record dopamine
signaling in vivo with high precision. The proposed work aims to determine the performance metrics of the newest
dLight variants in vivo and use the sensor to measure alterations in dopamine activity in a disease model.
Specifically, I will measure differences in dopamine signaling between offspring of the maternal immune
activation model and healthy controls, as offspring from this model have been shown to have altered dopamine
signaling systems. Additionally, I will create a database of the data collected to share with the neuroscience
research community, increasing the accessibility of dLight and enabling researchers to use this novel tool in their
own research. Successful completion of this project has the potential to transform our understanding of dopamine
biology and significantly contribute to the development of effective treatments for many neurological and
neuropsychiatric disorders.

Public health relevance
Project Narrative Altered dopamine signaling is a major characteristic of many neurological and neuropsychiatric disorders including schizophrenia and Parkinson’s disease. Due to a limited understanding of dopamine biology in both healthy and diseased states, we lack effective treatments for these disorders. The newest dLight variants provide the ability to measure dopamine dynamics with unprecedented precision, and this proposal aims to characterize the performance of the newest versions of this sensor in regions throughout the brain in both healthy animals and offspring of a maternal immune activation disease model.